Rational Combined Inhibition of NF-kB and EGFR to Optimize Lung Cancer Treatment

PROJECT ABSTRACT. Somatic activating mutations in the kinase domain of the epidermal growth factor
receptor (EGFR) drive the growth of 10-20% of non-small cell lung cancers (NSCLCs), the leading cause of
cancer mortality1,2. EGFR tyrosine kinase inhibitors (TKIs) are effective in many EGFR-mutant NSCLC
patients1,2. However, this clinical efficacy is limited by innate, adaptive, and acquired EGFR TKI resistance that
prevents long-term patient survival3-6. Identifying the mechanisms that limit EGFR TKI response is essential to
improve clinical outcomes. When EGFR-mutant patients do respond to initial EGFR TKI treatment, the responses
are typically incomplete because some tumor cells persist and survive as residual disease through poorly
understood mechanisms5,7-10. These residual disease cells form a reservoir of EGFR TKI-tolerant cells that
eventually grow to cause acquired resistance. There is an urgent need to define the molecular events that allow
these EGFR-mutant tumor cells to persist as residual disease during initial EGFR TKI treatment in order to design
therapeutic strategies to intercept this process and thereby improve the magnitude and duration of EGFR TKI
response in patients. From its inception, the goals of this project have been to: (a) understand the mechanism(s)
by which NF-kB limits EGFR TKI response and (b) identify a small molecule inhibitor of NF-kB that can effectively
and safely enhance EGFR TKI response in EGFR-mutant NSCLC. In ongoing studies funded by this project, we
have made progress towards achieving these goals7,11-20. Our initial studies demonstrated NF-kB is a promising
target to overcome innate and prevent acquired EGFR TKI resistance, through experiments that revealed a novel
role for EGFR TKI-induced adaptive activation of NF-kB in driving incomplete response and the residual disease
that is a prelude to acquired resistance. We showed the novel direct NF-kB inhibitor, PBS-1086, can be combined
safely with an EGFR TKI to enhance response, suppress residual disease, and prevent acquired resistance in
preclinical EGFR-mutant NSCLC cellular and animal models7. Based on our work, PBS-1086 is undergoing
clinical development. We now seek to extend this project in novel directions to dissect the mechanism by which
NF-kB mediates tolerance to EGFR TKI treatment to promote the residual disease that fuels acquired resistance.
We will test the innovative hypothesis that NF-kB drives unexplained and emerging features of drug-tolerant
persister cells during EGFR TKI treatment: (1) apoptotic resistance (Aim 1) and (2) de novo gain of EGFR TKI
resistance mutations (Aim 2)7-9,21. These persister cell features arising via NF-kB activation could be mutually
reinforcing by simultaneously enabling tumor cell plasticity, survival, and genetic adaptation to promote the
evolution of EGFR TKI resistance. We are pursuing a long-term strategy to define the function of NF-kB in limiting
response to EGFR TKI treatment to guide future efforts to rationally deploy inhibitors of NF-kB signaling or of its
key targets in order to better constrain the evolution of resistance and improve clinical outcomes.

Public health relevance
PROJECT NARRATIVE. Lung cancer is a major public health problem because it is the most common cause of cancer-related death in the US. Treatments that specifically target proteins that drive lung cancer growth, such as EGFR inhibitors, are leading to improved responses in lung cancer patients but success is limited because treatment resistance occurs. The studies in this grant proposal focus on the discovery of new mechanisms of resistance to EGFR inhibitors in lung cancer. Findings from our studies will hopefully lead to improved treatments that overcome resistance to EGFR inhibitors by allowing for the design of rational combination therapies. Our findings will have a major impact on lung cancer by optimizing personalized treatment strategies that will increase the survival of lung cancer patients.